Promoting child language acquisition through a preventive parenting intervention

Project Summary/Abstract
The primary aim of the proposed Administrative Supplement is to examine the effect of a preventive
intervention (IBP) on promoting early expressive language and reducing rates of late talking in young children
during their second to third years of life. It capitalizes on our Parent R01 recruitment of young children from
traditionally underserved and underrepresented backgrounds (i.e., ethnic/racial minority and low-income
families) to examine the effect of a parenting intervention on promoting early expressive language and
reducing rates of late talking (i.e., toddlers who acquire expressive language at a slower rate than their peers).
Research shows that children identified as late talkers during their second and third years of life are more likely
to show impairment in language and academic functioning at age 17 years. Additionally, young children living
in poverty are twice as likely to have delays in expressive language, with evidence of the association between
caregiver distress and dysregulated caregiver-child interactions with child language delays. However, research
examining interventions for late talking is sparse and methodologically limited (e.g., no randomization, small
sample sizes, lack of participant diversity). Additionally, most research has excluded important variables that
places certain populations at increased risk, such as poverty and caregiver distress, and have not examined
language before the fourth year of life, a critical developmental period when expressive language is first being
used. The proposed supplement builds upon our pilot work, which was the first to examine the effect of an
intervention targeting externalizing behavior problems, the Infant Behavior Program (IBP), on expressive
language during the second year of life. We will replicate and extend these effects of the IBP to expressive
language and late talking in a rigorously designed randomized controlled trial (RCT) using an active control
condition and multimethod assessment of language and with a larger sample with children from predominately
low-income and ethnic/racial minority backgrounds. We will also examine the theoretically-informed mediators
(i.e., caregiver language input and caregiver-child interaction) and theoretically-informed moderator (i.e.,
caregiver distress) of intervention effects. This study will be the first to examine the efficacy of a preventive
caregiver intervention on late talking in a larger, adequately powered RCT (n = 184), with participants from
diverse ethnic/racial, socioeconomic, and linguistic backgrounds (94% ethnic/racial minority, 88% dual
language learners), and using multimethod assessment of language (naturalistic recordings with LENA;
videotaped caregiver-child interactions; and caregiver report on the MacArthur-Bates Communicative
Development Inventories). This proposal falls within the scope of the Parent R01 and responds directly to
NICHD’s Notice of Special Interest to increase understanding of late language emergence. Findings would
support IBP for children identified as at risk for late talking and provide insight into how and for whom caregiver
interventions reduce risk.

Public health relevance
Project Narrative Late talking and delays in the development of expressive language in early childhood predict negative outcomes in language and academic functioning during adolescence, especially among children from ethnic/racial minority and low-income backgrounds. We are evaluating the effect of a brief remote parenting intervention on promoting early expressive language and reducing rates of late talking. Findings from this study will have important and timely public health implications to increase understanding of and intervention for late language emergence.